Optimal early colorectal cancer screening initiation

PROJECT SUMMARY
Colorectal cancer (CRC) accounts for 8% of cancer incidence and 9% of cancer-related mortality in the
United States (US). About 11% of CRC cases are diagnosed before age 50—known as early age onset CRC
(EOCRC)—with incidence and mortality rates increasing 1.6% and 1% per year between 2005-2014, and an
unequal burden among Asian, American Indian/Alaska Native, Black and Hispanic racial/ethnic groups and
those with Medicaid or uninsured. The increasing EOCRC burden informed a US Preventive Services Task
Force (USPSTF) recommendation to initiate CRC screening among average risk adults starting at age 45,
rather than 50. This recommendation would expand CRC screening to 21 million Americans, with 4 million
more turning 45 each year. There is a lack of evidence to inform how to optimize impact of CRC screening
among adults ages 45-49. Specifically, there are three critical knowledge gaps: 1) we lack information
regarding acceptability of CRC screening among those ages 45-49 and have not investigated factors that
might influence CRC screening uptake among this newly eligible population, 2) there are concerns that CRC
screening disparities that exist among adults ages ≥50 are likely to emerge in this younger age group without a
targeted screening strategy and 3) it is unclear whether this age group will respond to current CRC screening
practice or more active outreach. The central objective of this proposal is to develop a targeted CRC screening
strategy among adults ages 45-49 to maximize screening uptake and prevent cancer disparities. Our study will
recruit adults ages 45-49 receiving care within a large health system to answer these questions. First, we will
characterize the acceptability of CRC screening by running a pilot trial to establish feasibility of a larger trial
(Aim 1a) and conduct surveys and interviews regarding factors influencing CRC screening uptake (Aim 1b) to
highlight effective strategies for implementing screening among adults ages 45-49. Next, we will use these pilot
data to inform a randomized controlled trial of the comparative effectiveness of an active outreach strategy
including mailed fecal immunochemical test versus usual care for optimizing uptake and preventing emergence
of CRC screening disparities (Aim 2). This research plan is complemented by a training plan to enhance the
applicant’s background in epidemiology and biostatistics, with new training in 1) randomized controlled trials
methodology, 2) health behavior and medical decision making research, 3) health equity and disparities
research and 4) survey and qualitative research methods. Our study will be the most comprehensive
examination of early CRC screening initiation in the US to date and will provide context to the updated CRC
screening policy and a potential framework for wider implementation of earlier CRC screening in adults ages
45-49. It also offers a high-quality career development opportunity to develop key skills to become a qualified
independent investigator.

Public health relevance
PROJECT NARRATIVE Increases in early age onset colorectal cancer (EOCRC) incidence over the last two decades informed a recent United States Preventive Services Task Force recommendation to initiate CRC screening earlier at age 45 instead of age 50. In the newly eligible population of adults ages 45-49, it is unclear 1) if they are willing to undergo screening, 2) if screening disparities will emerge in this younger age group without a targeted strategy and 3) whether this group will respond to current strategies for promoting screening through usual care and outreach. The proposed study intends to address these evidence gaps by conducting a pilot trial, surveys and interviews to characterize the acceptability of CRC screening among adults ages 45-49, and then use these data to inform a larger randomized trial comparing an active outreach strategy to usual care with the overarching goal to maximize screening uptake and prevent screening disparities.